Targeting Kinases in Novel Preclinical Models of Adrenocortical Carcinoma

Adrenocortical carcinoma (ACC) is a deadly malignancy with survival <35% at 5 years and occurs across the
lifespan afflicting both young and older male and female veterans. Current treatment options of surgery,
mitotane and chemotherapy are inadequate. The mechanisms underlying ACC tumorigenesis are poorly
understood. Patients with genetic syndromes have an increased risk of ACC; however, the majority of cases
are sporadic. To date, no pathway has been successfully targeted in ACC in clinical trials. Lack of progress in
the field has been attributable to the lack of cell and animal models of ACC. Until recently, only one ACC tumor
cell line and no animal models were available. We have approached this unmet need by the development of
4 new human ACC cell lines and the first patient derived xenograft (PDX) animal models (N=5) with a strategy
to use these pre-clinical models to test bioinformatically identified targets for novel therapeutics. Our
overarching goal is to understand the diverse molecular pathogenesis of human ACC and identify novel targets
to test in our new cell and animal models. We analyzed multiple publically available genomic databases for
candidate genes that are dysregulated and noted that ACC tumors harbored a consistent dysregulation of cell
cycle control and DNA damage pathway constituents. We identified PBK (PDZ binding kinase) as the highest
dysregulated candidate. PBK has been identified as a master regulator of mitotic proteins and is critical for
cytokinesis. Its downstream effectors are cell specific. Although low or undetectable in most normal human
tissues, it is overexpressed in diverse cancers including breast, colon, lung, prostate and lymphomas. Our
preliminary data show that PBK controls the tumorigenic phenotype in ACC and that targeting PBK with either
shPBK or the PBK inhibitor, HITOPK032, reduced cell proliferation and tumorigenic growth in our pre-clinical
models. This application will dissect the mechanisms by which PBK inhibition or targeting exert their anti-
tumorigenic effects. In addition, we propose to test the effects of PBK targeting in combination with Mitotane
therapy, the only FDA approved drug for adrenal cancer. These studies will test the hypothesis that disruption
of specific components of cell the cycle in conjunction with Mitotane, a known ER stress inducer, will enhance
the anti-tumorigenic responses. Our novel ACC cell lines and PDX models provide a unique opportunity to
advance the understanding of the diverse mechanisms of adrenal cancer tumorigenesis as well as test for the
first time relevant ACC targets that will allow translation to our patients in the clinic. Our studies will fill an
unmet need in the area of endocrine tumorigenesis that afflicts veterans of all ages and shed light into the
biology of this poorly studied cancer. In addition, the data will provide insight into other cancers with these
mitotic kinase drivers which affect veterans every day.

Public health relevance
Adrenocortical carcinoma (ACC) occurs across the lifespan in young and older veterans and is an aggressive malignancy with poor survival of <35% at 5 years. Patients with genetic syndromes including Li-Fraumeni, Beckwith-Wiedmann and Lynch syndrome are predisposed to developing ACC; however, the majority of cases have no known cause. Slow progress in the field has been attributable to the lack of any preclinical models. We have transformed the field with the first new ACC cell lines and patient derived xenograft mouse models (PDX). We then used bioinformatic approaches to identify alterations in cell cycle and DNA damage repair pathways as new targets to explore mechanism of action. This proposal will focus on the role of a dysregulated mitotic kinase in ACC, PBK. Our models will allow testing of PBK inhibition together with Mitotane towards a new treatments for our patients with this deadly disease.